Mapping the origin of HER2 plasticity in breast cancer

PROJECT SUMMARY
While HER2+ breast cancers exhibit a favorable outcome due to the use of HER2-targeted agents, response
depends on HER2 status; tumors with residual HER2 expression (HER2-low) do not respond. HER2-low status
have been described in triple negative (TNBC) and ER+ breast cancers, and includes primary tumors, metastases,
and circulating tumor cells (CTCs). Recently, patient benefit has expanded to HER2-low tumors with the
development of HER2-targeted antibody-drug conjugates (ADCs), which suggest that the presence of a small
reservoir of HER2-low cells is therapeutically actionable.
CTCs isolated and cultured from HER2-, metastatic ER+ and TNBC patients can divide to produce HER2+
cells with as few as four population doublings, without the acquisition of genomic alterations that activate HER2.
Similar results were obtained from HER2+ CTCs, which can dynamically yield HER2- daughter cells with similar
division kinetics. While these results suggest that HER2-low breast cancers respond to HER2-targeted ADCs at
least in part because of the maintenance of a HER2+, heterogeneous state, current studies do not provide
mechanistic insight to explain how HER2 expression is dynamically regulated in breast cancer, nor whether
dynamic HER2 expression can be augmented in order to improve patient outcome.
Because prior studies demonstrate the (1) rapid and plastic conversion of HER2- cells to HER2+ cells and vice
versa, and that (2) this process occurs in the absence of known genetic events or changes that support HER2
expression or activity, we hypothesize that epigenetic, or epigenomic, features drive the dynamic
expression of HER2+ cells in otherwise HER2- tumors. To this test hypothesis, we will employ
characterized cell culture models of heterogeneous HER2+ breast cancer and HER2-low TNBC, and characterize
epigenomic features of HER2 lineage evolution. First we will define exogenous factors that influence HER2
heterogeneity and plasticity, and extend these studies by examining whether intrinsic features of HER2 (e.g.,
protein stability or DNA methylation) contribute to HER2 dynamics. We will then employ lineage trajectory
analyses with single cell multi-omics (scRNAseq and ATACseq) to establish the transcriptional features that
enable HER2+ daughter cells to arise from HER2- parent cells, and vice versa. Inclusion of single cell ATAC-seq
will inform how chromatin accessibility contributes to the mechanisms that enable HER2 plasticity at single cell
resolution. Lastly, because HER2-targed ADCs such as T-DXd improve patient outcomes for HER2-low breast
cancers, we will examine how the use of T-DXd modulates the HER2-low reservoir and observed plasticity
between HER2- and HER2+ cell states. Successful completion of this project will characterize the non-genetic
features that contribute to dynamic and heterogeneous HER2 expression, and begin to address larger question
of whether epigenetic therapies could be employed to augment the production of HER2+ cells in otherwise
HER2- tumors, which is therapeutically actionable.

Public health relevance
PROJECT NARRATIVE Some breast cancers across molecular subtypes harbor low levels of HER2 expression, and recent clinical studies show that in some cases, these tumors are responsive to HER2-targeted antibody drug conjugates. Patient HER+ and HER2- circulating tumor cells can rapidly interconvert in the absence of genomic alterations, suggesting an epigenetic mechanism governs HER2 plasticity. Here we will leverage innovative single cell epigenetics and transcriptomics to examine the role of the epigenome in maintaining HER2 intratumoral heterogeneity, with the long-term goal to reprogram tumors to support a therapeutically actionable reservoir of HER2-low cells.